Tracking structural brain changes at 0.05T using densely sampled neuroimaging, autonomous control, and super-resolution reconstruction

SUMMARY
This study aims to demonstrate accurate quantification of changes in brain morphology at 0.05T. We plan to
accomplish this tracking by exploiting the portability of our 0.05T scanner to acquire dense temporal sampling of
neuroimaging data coupled with autonomous control and deep-learning-based super-resolution reconstruction.
Magnetic Resonance Imaging (MRI) has been the primary tool to investigate these disorders, highlighting
structural, functional, and metabolic changes. For example, 3T structural MRI data have significantly improved
our understanding of the youths’ developing brain in health and disease. Recent studies have highlighted the
need for densely sampled temporal neuroimaging data to maximize clinical insight in patients with mental health
challenges. High-field systems' cost, power, and siting requirements impede dense longitudinal imaging in large
populations, especially in low-resource settings. In contrast, we hypothesize that a portable 0.05T can deliver
the required densely sampled neuroimaging data. We expect equivalent statistical power in detecting brain
changes associated with young adults at 0.05T with a five-time-point than a two-time-point 3T study. However,
0.05T MRI suffers from lower spatial resolution and signal-to-noise ratio (SNR), impacting the volumetric
accuracy required to monitor brain changes using structural imaging. These limitations render these scanners
supplementary devices to high-field systems. For meaningful use, there is a critical need to develop novel
methods to produce low-field, structural MRI data statistically equivalent to or better than 3T data. To address
this gap, we hypothesize that three orthogonal acquisitions and using DL-based super-resolution reconstruction
of five-timepoint data from children (10 – 17 years) at 0.05T provide similar accuracy to two-timepoint 3T data.
We have demonstrated the image quality of 0.05T data in phantoms over thirty sessions and the pipeline for in
vivo data acquisition, reconstruction, and segmentation on one healthy volunteer. These data show the potential
of 0.05T data for brain volumetry and the benefits of consistent scanner operation and image quality. In Aim 1,
we will demonstrate the feasibility of our 0.05T scanning pipeline to track brain changes and address the need
for the high-density temporal sampling of neuroimaging data. Second, the deployment of 0.05T is affected by
artifacts caused by external magnetic interference, magnetic field inhomogeneity, subject motion, degrading
image quality, and scanner operation. To address these challenges, we will adopt our automated MRI methods
to 0.05T in Aim 2. The densely sampled temporal neuroimaging data will yield early, accurate, and personalized
developmental trajectories of the youth brain, with the potential to scale this project in an equitable and accessible
manner. These methods will enable the broader scientific community to perform previously prohibitive structural
MRI studies without compromising accuracy, especially in underserved settings.

Public health relevance
NARRATIVE Changes in brain morphology provide critical insights into a wide range of neuropsychiatric disorders. Using a portable 0.05T magnetic resonance imager, this study meets the need for the dense temporal sampling of neuroimaging data required to track structural changes in the amygdala, hippocampus, and gray and white matter volumes in youths. We will demonstrate accuracy in computing brain volumetric changes similar to 3T outcomes and help in deployment through consistent scanner operation and image quality.